Administrative Core

The function of this Core A will be to provide administrative support, oversight and efficient management of this PPG application with the overarching goal of ensuring the scientific progress and coordination of all projects. The Core will be directed by Dr. Ihaki Sanz (overall P.L, and Project 2 Leader). The Administrative Core will coordinate the inter-project, inter-departmental collaborative arrangements and arrangements between the University of Rochester and collaborators at UC Berkeley (Dr. Hellerstein, heavy water experiments) and UT Southwestern (Dr. Scheuermann, flow cytometry FLOCK analysis). The Administrative Core will also provide the Projects and Cores with a review of all expenditures on a monthly basis and will deal with University Accounting and Grants management offices concerning grant budgets. The administrative support provided by the Administrative Core will reconcile all budgets of the Projects and Cores, and oversee compliance with regulatory issues. For example. Core A will maintain direct linkages to the University Office of the Vice Dean for Research (Dr. Ed Puzas). These links will be used to keep an accounting of the funding and expenditures for the purpose of annual progress reports. In addition, the Administrative Core will be responsible for organizing meetings and seminars of the PPG investigators, as well as the meetings of the External Advisory Committee as outlined below.

Public health relevance
The function of this Core A will be to provide administrative support, oversight and efficient management of this PPG application with the overarching goal of ensuring the scientific progress and coordination of all projects.